Development of an Intravenously Delivered Nanofiber to Target MMP-2 in Aortic Aneurysms

PROJECT SUMMARY/ABSTRACT
Abdominal aortic aneurysm (AAA) is the most common aortic pathology, and accounts for approximately
10,000 deaths annually in the United States. While many preclinical therapeutics have shown great promise,
pharmacological interventions have not shown significant inhibition of AAA enlargement. The goal of this
proposal is to develop an intravenously administered nanoscale material that will specifically target aneurysmal
tissue and serve as the foundation for the development of a nanotherapeutic to prevent and/or regress AAA.
Towards this goal, our laboratory has developed and evaluated a novel intravascular targeted technology
based on peptide amphiphile (PA) molecules. We have designed and evaluated several PA nanofibers to
target features of the aneurysmal microenvironment including matrix metalloproteinase-2 (MMP-2), fragmented
elastin, and membrane type 1-matrix metalloproteinase (MT1-MMP). Our results demonstrated excellent
targeting for the MMP-2-targeting PA nanofiber. These data are ideal given that a key feature of the
pathophysiology of aneurysm formation is the upregulation of MMP-2, and that MMP-2 is overexpressed in
both small and large aneurysms. Thus, we hypothesize that PA nanofibers designed to specifically target
MMP-2 will bind to aneurysmal tissue and be biocompatible. To investigate this hypothesis, the Specific Aims
are to: 1) Characterize and optimize the structural properties and binding kinetics of PA nanofibers targeted to
MMP-2 in vitro. An MMP-2-targeting peptide has been incorporated into a PA sequence. We will determine
critical parameters for co-assembly with diluent PA to enable nanofiber formation. The resulting AAA-targeting
PAs will be characterized for nanofiber formation, structural dimensions, and MMP-2 binding kinetics of the
peptide and the co-assembled nanofiber. 2) Evaluate the binding specificity and duration of the MMP-2-
targeted PA nanofiber to aneurysmal tissue in vivo. We will induce AAA in the infrarenal aorta of male and
female Sprague Dawley rats by exposure to CaCl2 to test targeting capability of our PA nanofibers. We will
also determine optimal concentration, dose, and co-assembly ratios. We will then determine the binding
duration for the optimal nanofiber dose and co-assembly parameters. 3) Determine the biodistribution,
elimination, and safety of the targeted PA nanofiber in vivo. Specifically, blood, bile, urine, and all vital organs
will be assessed at multiple time points before/after administration of the targeted PA nanofiber to determine
biodistribution, elimination, and safety of the targeted PA nanofiber. Successful completion of this F32
research proposal will result in the development of a nanotechnology specifically targeted to aneurysmal
tissue, and serve as the foundation to develop an effective therapy to prevent and/or regress AAA formation.
The experience gained from this proposal under the mentorship of Drs. Kibbe and Ikonomidis, both established
investigators in topics relevant to this proposal, will facilitate my transition into an independent investigator by
enhancing my ability to develop, characterize, and test novel nanomaterials to treat chronic disease.

Public health relevance
PROJECT NARRATIVE Abdominal aortic aneurysm (AAA) is the most common aortic pathology and accounts for 10,000 deaths annually in the United States. This proposal investigates the development and use of peptide amphiphile nanofibers for targeting unique extracellular matrix features found in AAAs. This technology will serve as the foundation for a targeted therapeutic to prevent, diagnose, and/or regress AAA.